Biochemical Silencing of Maladaptive Inflammation in Heart Failure

Project Abstract
Pathologic remodeling is a central feature of heart failure. Remodeling is characterized by
oxidative stress and inflammation. Current pharmacological interventions only slow the
progression of heart failure and do not target the underlying pathology. Thus, an innovative
approach is needed to correct the underlying pathology and improve the function of failing hearts.
Extensive work has shown the association between inflammation and cardiac remodeling;
however, previous attempts to target inflammation in heart failure patients were ineffective. The
harmful effects of oxidative stress are mediated by reactive aldehydes formed by the oxidation
of lipid membranes. These reactive aldehydes possess two electrophilic moieties, which bind
with proteins forming aldehyde-modified protein adducts. The free aldehydic groups within these
modified proteins behave as aldehyde-modified damage associated molecular patterns
(ADAMPs) and elicit adaptive immune responses. Extensive studies show ADAMPs are
increasingly generated in failing hearts; however, no attempt has been made to diminish the
antigenicity of ADAMPs and examine their impact in heart failure. In the heart, there are small
histidyl dipeptides, such as carnosine, which can act as nucleophiles. Carnosine is synthesized
by the enzyme carnosine synthase, which could bind with reactive aldehydes. Our preliminary
studies show carnosine can bind with aldehyde modified protein adducts (like ADAMPs); its
levels are depleted in failing hearts; and supplementing the precursor amino acid (β-alanine)
improves cardiac function. Based on these preliminary results, we hypothesize that capping of
ADAMPs with carnosine could limit inflammation and improve cardiac function in failing hearts.
For this, we will examine the extent to which overexpression and deletion of CARNS affects
cardiac function in failing hearts. Furthermore, we will examine how altering the levels of
carnosine per se in the heart influences the capping of aldehyde modified protein adducts and
subsequent immune responses. These studies create extensive opportunities for professional
development and for the creation of new, fundamental insights into the pathophysiology of heart
failure.

Public health relevance
Project Narrative Heart failure is a complex disease with many different causes, symptom, and prognoses, yet common features to many presentations are inflammation and oxidative stress. This proposal seeks to determine the ability of the endogenous histidyl dipeptide carnosine to quench pro-inflammatory products of oxidative stress. Cardiac-specific overexpression and deletion of carnosine synthase will be used to determine carnosine-mediated changes to these products, as well as cardiac function and remodeling in failing hearts.